Translational Nonhuman Primate Regenerative Medicine and Gene Therapy/Genome Editing Resource Program

PROJECT SUMMARY / ABSTRACT
There is a critical need for investigators to have ready access to a dedicated resource to evaluate new
regenerative medicine and gene therapy/somatic cell genome editing applications with nonhuman primates for
the treatment of human diseases. This application is focused on meeting this need through the improvement
and validation of the rhesus monkey model and related tools and technologies to address new approaches to
treat inherited disorders that impact a range of organ systems; and by providing investigators with opportunities
to obtain data for new NIH grant applications and for the conduct of investigational new drug (IND)-enabling
studies. The potential ramifications of gene transfer/genome editing at any age underscores the importance of
rigorous assessments of safety in the rhesus monkey model system which closely recapitulates human
physiology. The proposed resource program will be of significant interest to investigators and a range of NIH
Institutes as the opportunities will cut across a spectrum of organ systems and diseases. The goals will be
accomplished through the following Specific Aims: (1) Enhance tools and technologies for translational gene-
based approaches in the rhesus monkey model for utilization by the research community; (2) Improve
preclinical xenogeneic models for use by the research community to study human hematopoietic cells in the
rhesus host; and (3) Launch the Translational Nonhuman Primate Regenerative Medicine and Gene
Therapy/Somatic Cell Genome Editing Resource Program for model validation and therapeutic testing. Our
translational team will meet the goals of the RFA by improving and validating the monkey model system for
translational research across the lifespan; enhancing biological resources, tools, technologies, and research
protocols; and utilizing an established and proven infrastructure that has a successful track record in providing
collaborative research opportunities to investigators nationwide. To ensure accessibility for investigators, a call
for validation studies will be circulated to launch the resource. The program will provide a pipeline for
preclinical and IND-enabling investigations for the development and testing of new treatments for a range of
common and rare diseases.

Public health relevance
PROJECT NARRATIVE There is a critical need for investigators to have access to a dedicated resource for evaluating new regenerative medicine and gene therapy/somatic cell genome editing approaches with nonhuman primates for the treatment of human diseases. The overarching goals of this application are to provide models, tools, and technologies to address safe and effective treatments across age groups, and ensure opportunities are available to obtain preclinical data that will lead to human clinical trials.